Visual Crowding

Summary
Crowding is a perceptual phenomenon in which a clearly discernible stimulus becomes unrecognizable
because of nearby `distractor' stimuli. Crowding affects core aspects of visual processing, including feature
integration, scene perception and reading. Because crowding is stronger in non-foveal vision, it strongly affects
individuals with central vision loss (e.g. macular degeneration), with substantial consequences for their quality
of life. Crowding has been explored extensively in human psychophysical studies. Functional imaging and
electrophysiological studies in humans have provided some neural correlates of crowding in early and midlevel
visual cortex, but the neural underpinnings of crowding remain largely unexplored and poorly understood. This
project will determine how crowded displays affect the representation of sensory information by neuronal
populations in low and midlevel cortex (encoding), how crowding affects the manner in which this sensory
information is used to make perceptual judgments (decoding), and whether the effects of crowding can be
mitigated by brief periods of sensory experience. In Specific Aim 1, we will record from neuronal populations in
primary visual cortex (V1) and V4 of macaque monkeys. We will test the hypothesis that crowding corrupts
sensory representations in these areas. We will determine how crowded displays affect neuronal responsivity,
tuning, and variability, and interneuronal noise correlations. Making use of recent advances in understanding
population codes, we will assess how chances in these response features combine to affect encoding of visual
information with crowding. In Specific Aim 2, we will train animals to perform a fine orientation discrimination
task, for target stimuli presented in isolation and with distractors. We will use a stimulus paradigm that allows
us to compute “psychophysical kernels”—a method for assessing perceptual strategy by which different
elements of a visual display are combined to make decisions. We will pair these behavioral measures with
recordings of neuronal population in V1 and V4, to infer the read-out strategy used by the animal to relate
sensory responses to perceptual decisions. These experiments will test the hypothesis that crowding arises in
part from suboptimal read out of sensory information. In Specific Aim 3, we will test whether brief periods of
visual adaptation can mitigate crowding. We hypothesize that adaptation can be used to improve the salience
of novel stimuli, with heightened salience resulting in improved perceptual performance. We will test our
hypothesis by measuring the population information for target stimuli in isolation or with distractors, under
control conditions and different adaptation states. We will also test whether adaptation alters the read-out
strategy used by animals in our orientation discrimination task. These experiments will reveal which aspects of
crowding are most plastic, and test for a novel functional benefit of sensory adaptation. Together our aims will
provide a comprehensive investigation of the neural basis of crowding, providing knowledge needed to develop
therapeutic and behavioral strategies to alleviate the quality of life issues caused by crowding.

Public health relevance
Project Narrative This project aims to determine the neural basis of visual crowding, a perceptual phenomenon that limits visual performance in complex visual displays (e.g. reading the page of a book) and strongly influences the quality of life of individuals with compromised foveal vision (e.g. those afflicted with amblyopia or macular degeneration) or dyslexia. By studying the neural mechanisms of crowding, we will be better able to develop therapeutic approaches to reduce its effects. More generally, by furthering our understanding of neural mechanisms of vision, we will be better placed to develop artificial vision systems (i.e. visual prosthetics) and to facilitate recovery of vision after injury (e.g. stroke).